Ion signaling, cell transitions, and organ scaling during fin regeneration

PROJECT SUMMARY
Organs “know” when and how to stop growing to arrive at the correct size and shape. Disruption of organ size
control mechanisms leads to congenital abnormalities, poor organ homeostasis and tissue repair, and tumors.
Exemplifying this fundamental mystery, adult zebrafish fins perfectly regenerate to their original size and shape
regardless of injury extent. Therefore, zebrafish fin regeneration is a compelling and tractable system to
interrogate “organ scaling” mechanisms. Bioelectricity, or ion flows across cell membranes, is long-associated
with both organ size control and regeneration. However, links between ion signaling and their effectors to
specific cell behaviors determining organ size are limited. Perturbed ion signaling, notably by elevated voltage-
gated K+ channel activity and inhibited Ca2+-dependent calcineurin signaling, leads to dramatic overgrowth of
regenerating zebrafish fins. A distal fibroblast-lineage pool of "niche" cells within the fin's regenerative
blastema sustains fin outgrowth. The niche progressively depletes as outgrowth slows, likely by net re-
differentiation to a non-growth promoting state. We recently discovered the classic longfint2 mutant phenotype
is caused by ectopic expression of the Kcnh2a potassium channel within the fibroblast/niche lineage. Ectopic
Kcnh2a disrupts orderly niche depletion, thereby prolonging the outgrowth period. Kcnh2a likely blocks Ca2+-
calcineurin signaling with both acting uniquely during late stages of regeneration. We made a Ca2+ responsive
GCaMP6s transgenic reporter line and found distal fibroblast / niche cells exhibit dynamic Ca2+ fluxes. Our
single cell transcriptomics identified candidate upstream voltage-gated Ca2+ channels. We mutated the genes
encoding each channel, generating the first recessive model of dramatically elongated fins. We now
hypothesize niche-specific Ca2+ signaling, modulated by a cadre of Ca2+ channels, activates calcineurin to
promote niche-to-mesenchyme state transitions. We will pursue three Specific Aims to test this model and
identify mechanisms linking ion signaling to cell behaviors restoring fin size: 1) Characterize spatiotemporal
cytosolic Ca2+ dynamics and calcineurin activity in wildtype and long-finned zebrafish, 2) Determine how
voltage-gated Ca2+ channels modulate regenerating fin Ca2+ dynamics and fin outgrowth, and 3) Determine
how Ca2+ dynamics and calcineurin promote cell behaviors for fin growth cessation. Our proposed research will
associate voltage-gated Ca2+ channel-modulated intracellular Ca2+ dynamics, downstream calcineurin signaling,
and a novel “niche” state transition towards answering the classic mystery of robust organ scaling during fin
regeneration. Our study's broader impacts include identifying conceptual and mechanistic links of bioelectricity
to specific molecules and cell behaviors that determine organ size and form. Finally, studying robust adult
zebrafish skeletal regeneration will inform regenerative medicine approaches for human bone disease.

Public health relevance
PROJECT NARRATIVE Disrupted organ size control mechanisms underlie a multitude of birth defects, deficient tissue repair, and cancer. The proposed research studies cellular and molecular processes that perfectly restore size and scale during an astonishing example of innate vertebrate organ regeneration. As such, the project will uncover conceptual and specific mechanisms that may be disrupted in human disease while also guiding novel regenerative medicine approaches.